Targeted Degradation of HIV Integrase as a Novel Treatment of Infection

Targeted Degradation of HIV Integrase as a Novel Treatment of Infection
PROJECT SUMMARY
Due to the development of antiretroviral therapy, HIV-1 infection is no longer a death sentence but rather a
treatable chronic disease, providing people with HIV an almost normal life expectancy. However, the most recent
WHO HIV Drug Resistance Report indicates that the prevalence of acquired and transmitted HIV drug resistance
has exponentially increased in the recent years. The prevalence of three and four-class resistant HIV is already
estimated to range from 5 to 10% in Europe, while somewhat lower rates are still reported for North America
(<3%). Indeed, pan-resistant viruses against some drug classes have already been reported. It seems inevitable
that fully drug resistant viruses will arise in the not-too-distant future, which necessitates the development of
novel anti-HIV drugs. Rather than continue to design new inhibitors for drug-resistant HIV, we propose an
alternative strategy – the development of proteolysis-targeting chimeras (PROTACs) using existing anti-HIV
drugs. PROTACs are small, bifunctional molecules that contain a warhead domain specific to the targeted protein
of interest coupled by a short linker to an E3 ubiquitin ligase binding domain. Rather than working as a classical
inhibitor, these small molecules promote ubiquitination and subsequent proteasomal degradation of the target
protein. Using this technique to degrade pathological proteins has the added benefit that PROTACs can often
be used at concentrations significantly lower than standard inhibitors, as there is no need for PROTACs to be
present at stoichiometric concentrations. Once a PROTAC induces ubiquitination of the target protein, the protein
is degraded and the PROTAC is free to bind another protein and repeat the cycle. Of particular importance to
this project is that the transient nature of PROTAC interaction with, and subsequent ubiquitination of the target
protein means that a high affinity drug-target interaction is not as necessary as with classical stoichiometric
inhibitors. Indeed, PROTACs developed for oncogenic kinases using existing inhibitors as the warhead domain
were able to induce degradation of kinases with mutations that conferred resistance to the same inhibitors. We
postulate that it will be possible to target HIV proteins in virus that has become resistant to the inhibitory effect
of a drug with the corresponding PROTAC, due to the lower binding affinity required for degradation compared
to inhibition. Our early stage PROTACs designed to induce degradation of the HIV integrase enzyme show
nanomolar efficacy in both proteolysis of integrase, as well as a blockade of de novo HIV infection in T cells
using well-established assays. This application combines the expertise of investigators in PROTAC design and
biological assay development with that of an established research team at an NIH CFAR site. Our goal is the
development of proof-of-principle PROTACs that test the hypothesis that PROTACs are active against viruses
that have developed resistance mutations in the viral protein that is targeted by the PROTAC warhead. As
expected for an R21 application, this is a high-risk proposal; but if successful, the outcome will provide new
avenues for anti-HIV drug development for the increasingly resistant HIV virus.

Public health relevance
Project Narrative Management of HIV infection is facilitated by a number of current antiretroviral therapies that effectively block HIV function. However, the probability of patient relapse increases over time, as HIV mutates and becomes resistant to approved therapeutics. This project involves the development of a new class of compounds that can target both the original and the mutated form of HIV, allowing for long-term management for HIV patients.